FAIR Data Competency and Machine Learning Readiness for Biomedical Scientists

Project Summary/Abstract The Academic Science Education and Research Training (ASERT) program for postdoctoral scholars at the University of New Mexico (UNM) matches PhD graduates with outstanding biomedical research mentors and engages New Mexico’s diverse populations through effective science education collaborations with minority serving institution (MSI) and national tribal college partners. The overall objective of ASERT is to contribute to the number of junior faculty across the country with the training and experience to succeed in all facets of academic life at institutions that are likely to have highly diverse student populations and where interdisciplinary, collaborative research is essential for success. The present supplement request will expand the professional development of ASERT fellows and interested associate members in Findable, Accessible, Interoperable and Reusable (FAIR) data management and data analyses using machine learning. The proposed training is a critical training need for investigators in the biomedical sciences due to the increasing complexity of the datasets, a need for improved data stewardship to ensure data usability, and to enable new discoveries through effective use of existing data and facility in linking to new data. Faculty with extensive expertise in FAIR data management, machine learning, and biostatistics will develop and implement a training program consisting of eight modules that encompass the overarching principles of: 1) Obtaining data / Data management and processing; 2) model training; 3) model evaluation; 4) model improvement. There is strong institutional support for the training program beyond the supplement period, including opportunities for a deeper dive into modern AI/ML techniques, and managing diverse data sets in accordance with FAIR standards afforded by an advanced, mentored Biomedical Data Science course. Fellows will share information on opportunities in data science with undergraduate students at ASERT IRACDA partnered Minority Serving Institutions. Publication and presentation at the National IRACDA Conference will serve to further disseminate and share training resources.

Public health relevance
Narrative The University of New Mexico Academic Science Education and Research Training program aims to increase the number of new college and university faculty. Trainees are prepared to excel in all facets of academic life at institutions likely to have highly diverse student populations. Training is achieved in part through focused career development and skill-building activities. The present supplement supports focused skill building in data science and analyses of complex data sets to speed discoveries benefitting human health.